Norovirus regulation via bacterial modulation of interferon-lambda

PROJECT SUMMARY/ABSTRACT
Norovirus is the leading cause of epidemic gastroenteritis worldwide, but lacks an effective vaccine or
antiviral treatment. After infection, virus can be shed chronically for weeks to months, potentially contributing to
future outbreaks. A small animal model for persistent norovirus infection revealed that the commensal bacterial
microbiome enhances norovirus infection. Interferon-lambda (IFN-λ), an innate immune cytokine, plays an
important role in this process via an unclear mechanism. IFN-λ stimulates antiviral signaling on intestinal
epithelial cells, the same cells infected by persistent norovirus in vivo, and can prevent or cure infection.
Commensal bacteria may therefore promote norovirus infection by preventing host IFN-λ responses to virus.
Recent data also revealed that altered microbial communities in immunocompromised mice are associated with
excessive IFN-λ and norovirus resistance. A unifying hypothesis for these findings is that specific bacteria
diminish or enhance the capacity of intestinal epithelial cells to generate IFN-λ to regulate norovirus.
Identification of specific commensal bacteria that promote norovirus is critical to understanding in vivo
viral regulation. Dilutional fecal transplants and colonization experiments revealed a promising bacterial
candidate; comparison of this candidate to a related species that does not promote norovirus will highlight
bacterial phenotypic characteristics determining viral infection. The effects of this bacteria on specific
metabolites, as well as assessment of its localization in proximity to norovirus-infected cells in vivo, will be
explored. This proposal will also evaluate how this candidate bacteria regulates norovirus-permissive tuft cells.
Preliminary data indicates that bacterial products prevent IFN-λ induction by norovirus in vitro. Reporter mice will
be used to assay in vivo regulation of interferon signaling and viral infection by bacteria. The mechanisms by
which bacteria alter transcriptional responses to virus will also be interrogated in a novel in vitro intestinal
epithelial cell model. Finally, a fecal factor in immunocompromised mice confers norovirus resistance when
transferred, and correlates with excessive IFN-λ and altered intestinal bacteria. The role of IFN-λ in this viral
resistance will be tested using mouse lines lacking the IFN-λ-receptor, and the transferable factor will be
identified by treating transferred material and testing candidate isolates. Because the immunocompromised mice
have broad adaptive immune defects, different adaptive immune factors will be tested for their regulation of the
microbiome and the transferable factor.
Completion of this proposal will provide mechanistic understanding into the regulation of intestinal innate
immune signaling and norovirus infection by commensal bacteria. These studies will reveal bacteria with
modulatory effects on the intestinal epithelium to adapt for probiotic strategies to combat enteric viruses.

Public health relevance
PROJECT NARRATIVE Noroviruses are highly contagious viruses that cause gastroenteritis, commonly known as stomach flu, but there is no existing vaccine or treatment for these infections. Bacteria that normally reside in the intestine regulate norovirus infection, and different bacteria may promote or prevent viral infection by blocking or enhancing gut inflammation. Understanding how intestinal bacteria interact with norovirus is critical to development of oral vaccines and/or probiotic therapies for this pathogen.